Administrative Core

The Overarching Aim and long-range objective of the Yale MPMOD Administrative Core is to provide a
centralized office for the operation and coordination of the Yale MPMOD research activities and to promote its
efficient operation and ensure its vitality and success. The Specific Aims of the Yale MPMOD Administrative
Core are: 1) To facilitate the Program Director’s/Associate Director’s activities as overseer of the Scientific
Cores/Sub-Cores and of the overall progress of the Yale MPMOD, 2) To maintain Yale MPMOD receipt of orders,
budgetary and workflow records and billing, 3) To promote innovation in the Yale MPMOD Phenotyping
Core/Sub-Cores to meet client’s needs, 4) To coordinate communications between Yale MPMOD clients and
Core/Sub-Core Directors regarding receipt of orders, COUs, provision of services, communications of data,
billing and collections, 5) To coordinate shipping of mice to the Yale MPMOD, 6) To generate Letters of Support
for Yale MPMOD clients, 7) To coordinate Material Transfer Agreements/Conditions of Use Agreements, 8) To
administer the Yale MPMOD Vibrant Program, 9) To administer the Yale MPMOD Enrichment Program, 10)
To coordinate communications and achieve synergy and cost effectiveness between the Yale MPMOD and the
MPMOD Consortium and eliminate unnecessary overlap, 11) To maintain the Yale MPMPOD catalog of services
and curation of the Yale MPMOD website and 12) To work closely with the MPMOD Coordinating Unit to ensure
that records are stored appropriately.